Dissecting heterogeneity in hematopoietic stem and progenitor cell ontogeny

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The hematopoietic and immune landscape is complex. The assortment is generated and sustained by the function of hematopoietic stem cells (HSCs) and progenitor cells that arise independently during embryonic development. HSCs are characterized by their robust, lifelong self-renewal ability and differentiation multipotency, while HSC-independent progenitor capacities and lifespans are more limited. HSC and HSC-independent derived progeny can have distinctive functions with defects in the cells resulting in different disease states. Their important and unique properties are inherent and programmed during ontogeny. Currently, the functional differences between HSCs and HSC-independent progenitors are largely dissected with assays that require the removal of cells from their native microenvironment, with the measured differentiation outputs reflecting potential but not true endogenous functionality. Several studies have revealed discrepancies between native and transplantation-based assessments of HSPC function, underscoring the critical importance of examining a cell’s function within its native environment. We have developed several tools in zebrafish that classify HSC and HSC-independent progenitor functions within their endogenous embryonic/larval environments to fill this knowledge gap. We are now positioned to deploy the advantages of the zebrafish model to identify regulators influencing the formation and function of different HSC/HSC-independent progenitor subsets. In Aim 1, we will test the hypothesis that there could be unexpected connections among hematopoietic and immune cells and unrealized differentiation potentials of HSC/HSC-independent progenitors. We will use approaches that allow visualization and transcriptional characterization of HSCs, HSC-independent progenitors, and their progeny throughout the entire organism. In Aim 2, we will test the hypothesis that functional differences between HSCs, HSC-independent progenitors arise from their distinct spatiotemporal origins and via distinct genetic regulation. We will utilize temporal and spatial lineage tracing, whole mount in situ hybridization, in vivo genetic screening, and our new endogenous hematopoiesis functional assays to uncover the when, where, and how uniquely controlling the embryonic generation of HSCs, but not progenitors. In this project, we will address many unresolved questions related to HSC and HSC-independent progenitors arising during development including the differentiation repertoire of their progeny, the connections among lymphoid and myeloid immune effectors found throughout the organism, and the programs underlying the formation and functions of the wide-ranging stem and progenitor cells arising embryonically. This work will provide fundamental knowledge on the early establishment of hematopoietic and immune hierarchies relevant to understanding immune disorders and for the directed production of HSC and HSC-independent progenitors and their functionally distinct progeny from human pluripotent stem cell sources for treatment of a variety of disorders.

Public health relevance
Hematopoietic stem cells (HSC) and HSC-independent progenitors generate the variety of the hematopoietic and immune landscape needed to sustain an organism from embryogenesis until death. The proposed research is relevant to public health because it will provide fundamental knowledge on the early establishment of hematopoietic and immune hierarchies deriving from HSC and HSC-independent progenitors, which is relevant to understanding immune disorders and for the directed production of HSC and HSC-independent progenitors and their functionally distinct progeny from pluripotent stem cell sources.